Development Core

Project Summary/Abstract
The Developmental Core will be the backbone of the JH-E-dARC, working across the Research Cores,
investigators and users to enhance capacities and opportunities for rigorous engagement and scientific
advancement in structural determinants of health research, including stigma and health equity research.
Creating capacity building and research opportunities that support the career development and scientific
advancement of structural determinants of health research is critical in coming years, because the HIV
response increasingly requires attention to closing gaps in access to equitable treatment and prevention
outcomes across populations. We must invest now in developing and supporting the next generation of
scientists who will lead the science of reaching and serving these communities with interventions and services
to improve equity. Through the Developmental Core of the dARC, we will foster a culture of innovation,
investigator development and collaboration through activities drawing from our experience of scientific
mentorship, technical capacity development and career development support. We will draw upon a team of
experts with inter-disciplinary expertise. Specifically, we aim to: Aim 1: Develop a community of practice and
technical support to empower the next generation of stigma and structural determinants of health researchers.
Activities include a self-paced series of on-demand, short grant development videos that include content
specific to stigma and health equity concepts; internal review services for specific aims and coordination of
external reviews of grants; manuscript review and support on journal placement, revisions, and increasing
visibility and impact; and a seminar symposium series emphasizing career development. Aim 2: Advance the
proliferation and dissemination of science in measuring and responding to stigma and structural determinants
of HIV among emerging scientists. Bi-annual small grants will be made the Developmental Core, to support
new, stigma-related analyses of existing datasets. To bring in investigators new to these topic areas, we will
utilize mentorship models within the small grant system. Additionally, dissemination awards to report stigma-
related research at relevant conferences will be funded by the Core on a rolling basis to facilitate dissemination
and foster networking opportunities for early-stage investigators. Aim 3: Build partnerships with community
action groups, service providers and health departments to foster the meaningful engagement of impacted
communities in all phases of research. Core will liaise with community groups and representatives to build
academic-community partnerships for future grants. This process will improve the significance of grant
concepts by ensuring meaningful engagement with community partners and supporting the incorporation of the
priorities, ideas and capacities of community partners. Further, Core will support compensation of community
partners to engage in review of grant concepts and/or written text of academic grants. This process will better
integrate community input and mentorship within grant development and review.